MULTICENTER EVALUATION OF PILOCARPINE HCL IN SJOGRENS SYNDROME

This study is designed to determine if pilocarpine, administered orally as Salagen Tablets, is an effective treatment for the symptoms of xerostomia and xerophthalmia associated with Sjogren's syndrome; and if pilocarpine, administered orally, is safe in patients with Sjogren's syndrome.